Animal Models & Imaging

Project Summary/Abstract - ANIMAL MODELS & IMAGING SHARED RESOURCE
The Animal Models & Imaging Shared Resource (Animal Models) supports basic and translational cancer
research by providing UNMCCC members with guidance, collaboration, and services in animal models and in
vivo imaging for cancer research. Faculty Director Mara P. Steinkamp, Ph.D. (CMO) supervises the Resource,
which is operated by a full-time technical director with extensive experience in mouse models. The Cancer Center
Research Administration provides administrative support for the Resource, which provides a range of services
including experimental design, patient-derived xenograft implantation services, treatment and tumor monitoring,
in vivo imaging, and training in employing animal models. The Resource Faculty and Technical Directors
interface with the Health Sciences Center Animal Research Facility, which provides veterinary care and animal
husbandry services for all research animals. Reservations, billing and usage are tracked through a centralized
on-line system. The Resource Director and staff work closely with the Research Programs to develop new
methodologies that promote innovative basic and translational research. The Resource actively facilitates and
disseminates information about new in vivo technologies through an up-to-date web page and presentations at
UNMCCC meetings and retreats. During the previous funding period the Resource had 37 UNMCCC member
users who were supported by 43 peer-reviewed grants including 10 UNMCCC Pilot Grants. Work using the
Resource was reported in 23 peer-reviewed publications. In the reporting year of July 2019 – June 2020,
UNMCCC members were responsible for 95% of total Resource usage.